SAFETY AND TOLERANCE OF HIGH VERSUS LOW DOSE ZIDOVUDINE IN CHILDREN

This protocol is designed to determine whether there are differences in tolerance and side effects associated with two dosing schedules of AZT when used to treat HIV-infected children.